Transdisciplinary approaches to American Indian and rural population health research

Overall Summary
The purpose of the Transdisciplinary Center for Population Health (TCPH) COBRE is to facilitate the
development of American Indian (AI) and rural health research in South Dakota. The theme that defines this
center is the application of an ecological framework to address important issues in AI and rural health
populations. All of the projects incorporate transdisciplinary teams, including perspectives directly from the
involved populations. This initial and continuous engagement creates an environment where research results
can be immediately disseminated and applied. These selected Project Leaders have each started down the
path towards research independence and are on the cusp of being competitive at the R01 level. This
proposed COBRE center will allow for the needed mentorship and concentrated funding for that development
to occur. These Project Leaders will then graduate off of COBRE funding, assume larger mentorship roles
within the center, and allow for the recruitment of new researchers to build our capacity and increase the
impact of research on AI and rural health. A plan has been created with national training institutes that
specialize in AI and rural health research to help draw a new group of talented, energetic and creative
researchers to the region. The TCPH includes core services that focus on the unique regulatory needs of
human subjects research, particularly the complexity that exists with multiple research partnerships, and data
management and statistical tools to optimize the quality and utility of data.

Public health relevance
Overall Narrative The Transdisciplinary Center for Population Health COBRE will create an environment for junior investigators interested in American Indian (AI) and rural health needs to receive mentorship, resources, and opportunities to develop an independent research program. The TCPH will also draw energetic and talented new investigators to the region to promote impact and sustainability of the research program.